Alcorn State University: Penn State University Bridges to the Doctorate Program

DESCRIPTION (provided by applicant): Continued economic growth in the U.S. will be critically dependent on a pool of scientifically trained workers. Current predictions suggest that student participation in science and engineering is decreasing. However, there exist of pool of students that have traditionally been underrepresented in these fields, minority students. Significant efforts to recruit and train such students could lead to increased representation of these groups in science and engineering, and will also increase the number and pool of scientifically trained workers in the U.S. Current efforts to increased participation of groups traditionally not represented in science include activities that aim at increasing recruitment and preparation of such students for graduate school entrance. However, little effort has been made in retention of such students. The goal of this proposal is to continue a program between The Pennsylvania State University and Alcorn State University that has been preparing and retaining students traditionally underrepresented in biomedical sciences in the U.S. In pursuit of that goal, the objective of this application is to continue our comprehensive program that effectively increases the training opportunities and skill set of select Alcorn State University students, increasing their preparation for the rigors of graduate school, enhancing the research opportunities of select faculty at Alcorn State. Our rationale is that more effective preparation and retention strategies will lead to increased numbers of minority students who are traditionally underrepresented in the biomedical sciences. We have two specific objectives: 1) Recruitment of select Biological Sciences Masters degree program students at Alcorn State University to participate in the Bridges program at Alcorn State and Penn State, and 2) facilitate faculty exchanges between Alcorn State and Penn State in order to update research skills and enhance research breadth of faculty at Alcorn State. Using a combination of strategies designed to enhance retention of minority students in graduate school we have increased and expect to continue to increase the numbers of students transitioning from the Masters program at Alcorn State into PhD programs, particularly at Penn State. More importantly, we expect that these efforts will result in increased retention and receipt of PhD by students traditionally underrepresented in biomedical sciences. This will have a significant impact on the increase in the pool of scientifically trained workers in the U.S. who can contribute to continued research and development.

Public health relevance
PUBLIC HEALTH RELEVANCE: Continued economic growth in the U.S. will be critically dependent on a pool of scientifically trained workers. Current predictions suggest that student participation in science and engineering is decreasing. However, there exist of pool of students that have traditionally been underrepresented in these fields, minority students. The Alcorn State:Penn State Bridges to the Doctorate Program has been develop to increase the number of underrepresented minorities who go on to attaining the PhD. This will therefore increase the pool of scientifically trained workers in the U.S., and also increase the number of those who are minorities. Principal Investigator/Program Director (Last, First, Middle): August, Avery Continued economic growth in the U.S. will be critically dependent on a pool of scientifically trained workers. Current predictions suggest that student participation in science and engineering is decreasing. However, there exist of pool of students that have traditionally been underrepresented in these fields, minority students. The Alcorn State:Penn State Bridges to the Doctorate Program has been develop to increase the number of underrepresented minorities who go on to attaining the PhD. This will therefore increase the pool of scientifically trained workers in the U.S., and also increase the number of those who are minorities. . PHS 398/2590 (Rev. 09/04) Page 1 Continuation Format Page __SpecificAimsTextDelimiter__ Principal Investigator/Program Director (Last, First, Middle): August, Avery a. Specific Aims Continued economic growth in the U.S. will be critically dependent on a pool of scientifically trained workers. Current predictions suggest that student participation in science and engineering is decreasing. However, there exist of pool of students that have traditionally been underrepresented in these fields, minority students. Significant efforts to recruit and train such students could lead to increased representation of these groups in science and engineering, and will also increase the number and pool of scientifically trained workers in the U.S. Current efforts to increased participation of groups traditionally not represented in science include activities that aim at increasing recruitment and preparation of such students for graduate school entrance. However, little effort has been made in retention of such students. The goal of this proposal is to continue a recently developed program between The Pennsylvania State University and Alcorn State University, aimed at preparing and more importantly, retaining students traditionally underrepresented in biomedical sciences in the U.S. In pursuit of that goal, the objective of this renewal application is to continue and improve a comprehensive program that effectively increases the training opportunities and skill set of select Alcorn State University Masters students, increasing their preparation for the rigors of graduate school, and enhancing the research opportunities of select faculty at Alcorn State. Our rationale is that more effective preparation and retention strategies will lead to increased numbers of minority students who are traditionally underrepresented in the biomedical sciences. Specific Objectives 1. Recruitment of select Biological Sciences Masters degree program students at Alcorn State University to participate in the Bridges program at Alcorn State and Penn State. Select graduate students in the Biological Sciences Masters degree program at Alcorn State, as well as new applicants to the program will be recruited to participate in an onsite program with Penn State. These students will be able to take advantage of research laboratories and courses at both Alcorn State and Penn State to complete their Masters degree and transition into PhD programs at Penn State. 2. Facilitate faculty exchanges between Alcorn State and Penn State in order to update research skills and enhance research breadth of faculty at Alcorn State. Select faculty at Alcorn State and Penn State will participate in faculty exchanges to enhance research skills and interactions with recruited Alcorn State Masters students. We expect that these activities will result in increased numbers of students transitioning from the Masters program at Alcorn State into PhD programs, particularly at Penn State. More importantly, we expect that these efforts will result in increased retention and receipt of PhD by students traditionally underrepresented in biomedical sciences. This will have a significant impact by increasing the number of minority students earning PhD degrees, as well as increasing the pool of scientifically trained workers in the U.S. who can contribute to continued research and development. PHS 398/2590 (Rev. 09/04) Page 1 Continuation Format Page